Immune Responses To Human Pathogens

In this project we use flow cytometry and next generation sequencing approaches to interrogate antigen-specific B cell and T cell responses to microbial infections in humans. We also explore their interaction with innate immune responses to understand the dynamics of acute and chronic infections, and how this affects clinical outcome. Responses against viral and bacterial agents are considered. These studies address not only questions of basic immunology but also inform prophylactic (vaccine) and therapeutic (monoclonal antibody) strategies.